St. Jude Children's Research Hospital - Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) Operations and Collaborations Center (UM2 Clinical Trial Optional)

ABSTRACT St. Jude Children's Research Hospital
The Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) aims over the 7-year funding cycle
to develop and conduct innovative behavioral, community-based, translational, therapeutic, microbicide, and
vaccine trials in youth ages 13-24 years at-risk for HIV and living with HIV, with a focus on the inclusion of
minors. The ATN seeks investigators with innovative thinking and novel approaches to address the public
health issues facing adolescents. The St. Jude Memphis Site Consortium (SMSC), based in Memphis located
in the Shelby County of TN has (1) a well-established clinical and clinical research facility at St. Jude Children's
Research Hospital (former ATN site), (2) A long-standing Connect to Protect Memphis Coalition (C2P
Memphis) of over 25 stakeholders (Community Based organizations, Non for Profit Groups, Memphis Schools,
etc.) invested in the interests of youth and (3) established partnerships including with academia (University of
Tennessee) and the local Shelby County and Tennessee state health departments. Shelby County is an
Ending the HIV Epidemic Priority jurisdiction. The SMSC closely collaborating with the Westat led ATN
Operations and Collaborations Center (OCC) will participate in the development of clinical trials and provide
the clinical research site(s), local laboratory capacity, and investigational pharmacy support to further the ATN
Research agenda. Taking the clinical trials to youth at risk of HIV and those living with HIV who are not aware
of their diagnosis will require using innovative approaches for recruitment which the SMSC has demonstrated
in the past and looks forward to building on. The C2P Memphis Coalition and a separate youth community
advisory board will over the project period be instrumental in providing input both for clinical trial design as well
as youth engagement and retention approaches.